Human Organoid Models for Pediatric High-Grade Gliomas

Malignant pediatric high-grade gliomas (pHGGs), which infiltrate the brain and grow rapidly, are
a leading cause of cancer-related deaths in children. There is an urgent need for new
treatments for these tumors. Our research team and others have identified several related
fusion mutations in receptor tyrosine kinases (RTKs), such as MET, ALK, and NTRK, in pHGG
tumor cells. These mutations abnormally hyperactivate RTKs to cause pHGG cancer initiation
and progression. Up to 40% of pHGG tumors have these and similar RTK fusions. Several FDA-
approved specific tyrosine kinase inhibitors (TKIs) exist that target RTK mutations found in
pHGGs. However, treatment with TKIs is not sufficient to eliminate tumor cells in human
patients, despite compelling data from mouse models. Recent research has shown that human
neural cell types, including glia, display different developmental profiles, inflammatory
responses, and metabolic features and show greater developmental heterogeneity compared to
their murine counterparts. We predict that these differences may underlie human-specific
adaptations to TKIs and other RTK targeted therapies, particularly in the developing brain in
pediatric cancers. To test our hypothesis, we will Aim 1) create pHGG organoid models using
human patient-derived pHGG stem cells engrafted into human iPSC-derived brain organoid
cultures that approximate early postnatal human brain tissue, and Aim 2) model how
interactions between pHGG cells and the human neural microenvironment affect responses to
TKIs and other anti-tumor drugs. With our efforts, we hope to develop new humanized
experimental models for pHGG and to identify drug combinations that may be brought into
future clinical trials for this deadly disease.

Public health relevance
PROJECT NARRATIVE High-grade gliomas are among the most common and deadly malignant tumors of the central nervous system in children, and are incurable with current therapies. In this application, we propose to develop complex humanized pre-clinical organoid models of pediatric high-grade gliomas, and to use these models to determine the cell(s) of origin for tumors that are driven by gene fusion mutations. If successful, this project will establish human-specific organoid models as a new experimental modeling paradigm for pediatric high-grade gliomas.